Administrative Core

Project Summary/Abstract
The UCSF Brain Tumor SPORE has three overall specific objectives: 1) to identify novel immunomethylomics-
based biomarkers that contribute to the survival, diagnosis, and therapy response in glioma patients; 2) to
develop noninvasive imaging modalities that can define response to therapy in patients with IDH-mutant glioma;
and 3) to develop novel adoptive transfer therapy using autologous T lymphocytes that allow us to overcome the
current challenges for immunotherapy. The Administrative Core of the UCSF Brain Tumor SPORE has been
established to supervise the activities of the UCSF Brain Tumor SPORE and to provide fiscal management,
administrative support, and the framework by which researchers can communicate and interact. The specific
aims of the SPORE Administrative Core are: 1) To evaluate research progress. The Administrative Core, through
the SPORE Executive Committee, the SPORE Steering Committee, and the SPORE External Advisory Board,
will be responsible for evaluating the progress of projects and making decisions regarding the continuation or
replacement of projects. 2) To provide fiscal management. The Administrative Core will distribute funds from the
SPORE Award, the Career Enhancement and Developmental Research Programs, SPORE Supplement Awards,
and discretionary funds provided by the institution. The Administrative Core will also be responsible for timely
financial reporting to Project Leaders and the SPORE PI/co-PIs. 3) To provide administrative support. The
Administrative Core will be responsible for the daily operations of the SPORE, the preparation of SPORE-related
manuscripts, and communications with the NIH. 4) To facilitate communication between SPORE investigators
and between the SPORE and outside entities. The Administrative Core will be responsible for scheduling all
meetings, seminar series, and retreats, and distributing notices inviting participation in the Career Enhancement
Program and the Developmental Research Program. The Administrative Core also facilitates communication
with NIH and NIH-funded entities and the brain tumor patient community. 5) To assist in compliance. The
Administrative Core will be responsible for ensuring compliance and scientific integrity of all components of the
SPORE. The Administrative Core will be used by all Projects, Programs, and Cores in the SPORE.